INTERACTION OF GHRH AND GHRP ON STIMULATION OF GH IN NORMAL MAN

GHRH and GHRP stimulate GH release in man. The mechanisms, however, of action appear different. This study is designed to investigate the interaction of these peptides.